Behavioral Intervention Development Core

Project Abstract – BID Core
The scientific premise underlying this proposed Roybal Center is as follows: most known modifiable
intervention targets for, and outcomes of, EM have robust established evidence-based guiding behavioral
interventions in related fields. But there remains a need to adapt, refine, and implement these interventions to fit
the context of EM, in terms of behavioral interventions for its prevention (e.g., targeting caregiver risk factors)
and sequelae (e.g., targeting depression after EM) rapidly and effectively. We will initially focus on pilots
addressing stage 0-2 of behavioral intervention development. We will provide robust services and support
through the cores designed to ensure translation and progression of pilots through the NIH stage model by
targeting known barriers (e.g., regulatory and recruitment) to research progression for EM. By addressing these
known barriers in EM research up front at the pilot stage, we hypothesize that investigators can build sustainable
and impactful long-term research programs that will pave the way for developing and evaluating future
mechanism-focused EM interventions. The overall goal of the BIDC is to support NIH Stage 0-2 research to
generate interventions that (1) reduce risk of elder mistreatment (EM) by intervening at the level of known or
posited mechanism factors; and (2) reduce impact of EM once it occurs by leveraging evidence-based treatments
for known EM sequelae that specifically measure and target hypothesized mechanisms of behavior change. The
BIDC has two objectives. Objective 1. Each year, select and support 2 to 3 high-quality EM research pilot
projects, representing stages 0-2 of the NIH Model of Behavioral Intervention Development. Objective 2.
Systematically implement a training and mentorship process for all selected pilot projects, to overcome common
regulatory, recruitment, and technical barriers to completing translational EM research. The goal is to ensure
that each pilot project clearly identifies and assesses hypothesized mechanisms of behavioral change, and
subsequently progresses through the NIH Stage Model for Behavioral Intervention Development. Year 1 Pilots
include: (1) Ecological
Elder
Stage
Depression
Momentary Analysis of Heart Rate Variability as a Marker of Stress Reactivity &
Mistreatment Aggression Potential in New Stroke Caregivers: A Mixed Methods Approach - NIH
0; (2) Leveraging Adult Protective Service Interactions to Offer Evidence-Based Treatment for
in Elder Neglect/Self Neglect NIH Stage 1: (3)- Web-Based Support Program for AD/ADRD
Caregivers of Hospitalized Veterans Living with Dementia to Prevent Elder Mistreatment during Care
Transitions from Hospital to Home - NIH Stage 2.